Ferroptosis and Ferroptotic Stress in Maladaptive Renal Repair

PROJECT SUMMARY
Acute kidney injury (AKI) is a major health problem, afflicting 1.2 million hospitalized patients annually in the US.
Maladaptive renal repair after AKI promotes development of chronic kidney disease (CKD), leaving affected
patients at high risk for dialysis dependency, cardiovascular events, and mortality. Studies show that males are
disproportionately and more severely affected by AKI than females, including COVID-19-associated AKI.
However, the molecular mechanisms underlying this sexual dimorphism remain poorly understood. Moreover,
there are no targeted therapies that interrupt this devastating disease process in both sexes. Using single-cell
transcriptomics and mouse genetics, our ongoing studies found that the female sex confers marked protection
against ferroptosis, a distinct, non-apoptotic form of regulated cell death and a critical driver of maladaptive repair
after AKI in mice and humans. Ferroptosis is triggered by the inability of glutathione peroxidase 4 (GPX4) to
remove toxic lipid peroxides from cell membranes, leading to the accelerated accumulation of toxic lipid
peroxides (ferroptotic stress) and cell rupture. Acute ischemic and toxic kidney injuries reduce GPX4 in proximal
tubular (PT) cells, thus making these cells vulnerable to ferroptosis. Severe AKI also induces pathologic
transcriptional alteration of PT cells into an inflammatory phenotype and prevents their recovery to a healthy
state (impaired plasticity). Our data show that in males but not in females, genetic deletion of Gpx4 promotes
the accumulation of inflammatory PT cells and triggers their death by ferroptosis. To advance these clinically
impactful lines of investigation, we will test our overarching hypothesis that sexual dimorphism in resilience to
ferroptosis underlies sex differences in clinical outcomes after AKI. We further hypothesize that uncovering the
mechanisms of how sex hormones regulate ferroptosis sensitivity will enable identification of targetable
downstream pathways that improve AKI outcomes for both sexes. Directly testing these hypotheses, we will
integrate unbiased single-cell transcriptomics, genetic mouse models, pharmacological studies, and human
kidney organoids with two Specific Aims. In Aim 1, we will determine sex-dependent mechanisms by which
ferroptosis promotes maladaptive repair at single-cell resolution using our tubule-specific, doxycycline-inducible
Gpx4 knockout mouse model. We will also investigate the therapeutic effects of ferroptosis inhibitors to enhance
renal repair in our murine kidney injury models in vivo and in human in vitro AKI models using organoids. In Aim
2, we will test our hypothesis that sex hormones regulate the sensitivity to ferroptosis and PT cell plasticity after
AKI using gonadectomy and genetic inhibition of estrogen receptor signaling. The results of these studies will
provide compelling preclinical mechanistic evidence for how ferroptotic stress governs PT cell fate. Our studies
will identify new therapeutic targets to enhance renal ferroptotic stress resilience and promote healthy PT
recovery from injury, thereby interrupting the AKI to CKD transition in both sexes.

Public health relevance
PROJECT NARRATIVE Acute kidney injury (AKI) impacts 1.2 million hospitalized patients in the US annually and affects males more severely than females. Our proposed studies will determine the sex-dependent mechanisms for AKI and its recovery. Knowledge of these mechanisms will allow the development of new therapies to improve the recovery of kidney functions after AKI for both sexes.